The Development of Facial Motor Neuron Subtypes in Health and in Congenital Facial Weakness

PROJECT SUMMARY
Aberrant changes in mature neural connections and their function can be induced by infection and inflammation
within the brain. The intracellular protozoan parasite, Toxoplasma gondii, is one pathogen that infects the brain,
evokes a prolonged inflammatory response and can cause seizures. Persistent infection by this parasite is also
associated with behavioral alterations and is a considerable risk factor for developing psychiatric illness, includ-
ing schizophrenia. Over 30% of Americans are presently living with an incurable long-term infection of Toxo-
plasma gondii, yet, despite its prevalence and implications for serious neurological disorders, we lack sufficient
understanding of the effect of life-long parasitic infection on the brain – a major organ of the human body in which
the parasite invades cells. This study seeks to elucidate the underlying mechanisms of brain circuitry dysregu-
lation in long-term infection in response to this unmet need. Our recent studies have revealed that Toxoplasma
gondii brain infection causes changes in inhibitory circuitry (specifically the loss of inhibitory synapses) along
with changes in inhibitory neurotransmission, leading to the onset of seizures. Moreover, preliminary studies
demonstrating increased expression of classical complement cascade components, elevated microglial activa-
tion, and substantial microglial ensheathment of neurons and inhibitory nerve terminals, propose dynamic inter-
active roles for the innate immune system and resident-macrophages of the brain in altering functionally mature
neural circuits during parasitic infection. In this proposal, we test the hypotheses that molecular components of
the innate complement pathway mediate inhibitory synapse loss and seizures, and that microglia remove and
phagocytose these synapses following chronic Toxoplasma gondii infection. By capitalizing on multi-scale imag-
ing modalities, the aims in this proposal will deliver novel ultrastructural and real-time insight into the impact of
chronic parasitic infection on mature neural circuits and will offer a novel mechanism as to how persistent Toxo-
plasma gondii infection may contribute to both seizures and psychiatric illness. This study is directly aligned with
the NIH's Blueprint Program's mission to expand our understanding of the neuroimmune dynamic interactions
that give way to neurological disorders.

Public health relevance
PROJECT NARRATIVE Human infection with the widely transmissible parasite, Toxoplasma gondii, has surfaced as a major risk factor for developing psychiatric illness and neurological disorders, such as seizures. This project aims to reveal im- portant information on the dynamic neuroimmune mechanisms by which long-term parasitic infection alters neu- ral circuits in the brain – a critical step to creating preventative and therapeutic treatments in aid of these complex disorders.